University of North Carolina Global HIV Prevention and Treatment Clinical Trials Unit

Abstract
The University of North Carolina (UNC) Global HIV Prevention and Treatment Clinical Trials Unit
(CTU) has a well-established record of high quality, innovative clinical research, strong network
and scientific leadership. The CTU engages with critically important populations infected with and
at high risk of HIV in southeastern US, southern Africa and southeast Asia. Our CTU is led by
three experienced principal investigators (Joseph Eron MD, Mina Hosseinipour MD and David
Wohl MD) and will support all four NIH Clinical Trials Networks (CTN); Adult Therapeutic
Strategies, HIV Prevention, Vaccine Prevention and Pediatric, Adolescent and Maternal
Therapeutic Strategies. Our four experienced Clinical Research Sites (CRS) include Chapel Hill
CRS (Adult Strategies, Prevention and Vaccine CTN) led by Dr. Wohl, Greensboro CRS (Adult
Strategies, Prevention and Vaccine CTN) led by Cornelius Van Dam MD, Malawi CRS (all four
CTN) led by Lameck Chinula MD and Vietnam CRS (Adult Strategies, Prevention and Vaccine
CTN) led by Vivian Go PhD. Participants with HIV include those newly diagnosed (including with
acute infection), PWH stably suppressed on therapy and PWH with adherence challenges to care
or medication and those with drug-resistant HIV. At-risk populations include men who have sex
with men (MSM) including young men of color, transgender women (TGW), people who
inject drugs (PWID) and African adolescent girls and women including those who are pregnant.
We will enroll PWH at risk for comorbidities and PWH or without HIV with co-epidemic pathogens
such as tuberculosis (TB) and Hepatitis B virus (HBV). We have skilled, experienced clinical and
translational investigators working hand-in-hand with junior investigators with diversity of gender
and race, in US and international settings, who will engage and execute the network scientific
agenda. A globally representative set of senior scientists and public health leaders on our
Scientific and Strategic Advisory Group advise the CTU leadership team. The CTU administration
has a highly organized structure that is responsive to our research teams and CRSs. Each CRS
engages the communities representing the affected populations in an interactive, open-minded
way. State-of-art communication and experienced, outstanding and well-organized laboratory,
pharmacy, regulatory, quality and data management support the CTU, CRSs. Using this robust
framework the UNC Global CTU is positioned optimally to continue our scientific, and network
leadership and clinical trials support to the agenda of all four NIH HIV networks.

Public health relevance
Project Narrative The NIH established collaborative HIV/AIDS Clinical Trials Networks to advance the science of HIV prevention and treatment and to contribute to the end of the HIV epidemic. The UNC Global HIV Treatment and Prevention Clinical Trials Unit will contribute to the work of all four NIH HIV Clinical Trials Networks by enrolling those populations most affected by HIV and by providing innovate scientific leadership and by contributing to the leadership of the networks.